Phylogenetics, causal inference, and model diagnostics for longitudinal studies of infectious disease transmission and control

Project Summary/Abstract
Pairwise survival analysis is a set of statistical methods for studying the transmission of disease in house-
holds and other groups of close contacts. It correctly accounts for the transmission of disease from person to
person, giving it greater accuracy and statistical power than statistical methods borrowed from chronic dis-
ease epidemiology such as logistic and Poisson regression. Pairwise regression models can simultaneously
estimate the effects of covariates (e.g., vaccination status, age, antiviral prophylaxis, or wearing a mask) on
susceptibility to infection and on infectiousness, producing detailed epidemiological insights that can inform
public health interventions. This project aims to extend these methods in three ways. First, we will develop
efficient numerical methods to incorporate pathogen genetic sequences into parameter estimation. This
information can reduce bias and variance in parameter estimates by providing partial information about who-
infected-whom, but statistical inference with these data can be computationally expensive. We propose
efficient Bayesian Markov chain Monte Carlo (MCMC) algorithms that use a pruning algorithm to generate
proposals for transmission trees. Second, we will develop methods for assessing goodness of fit for pairwise
regression models and for calculating secondary attack risks and infectiousness profiles, which are important
determinants of the severity of an epidemic and the most effective methods of control. The SAR is the
probability of transmission from an infectious person to a given susceptible contact, and it is an important
determinant of the potential severity of an epidemic. The infectiousness profile tells us how infectiousness
changes over the course of the infectious period, so it determines how long an infected person needs to
take precautions around other people and how effective nonpharmaceutical interventions like quarantine and
isolation can be. The epidemiological insights pairwise survival models generate are reliable only if they fit
the data well, so epidemiologists and statisticians need to be able to evaluate and compare these models in
a manner similar to standard regression models in biostatistics. Finally, this project will develop graphical and
statistical methods to assess confounding and selection bias in infectious disease transmission data. To
inform public health interventions, we must understand the requirements for reliable causal inference.

Public health relevance
Project Narrative and Relevance to Public Health Pairwise survival analysis is a set of statistical methods for studying the transmission of disease in house- holds and other groups of close contacts. Pairwise regression models can simultaneously estimate the effects of covariates (e.g., vaccination status, age, antiviral prophylaxis, or wearing a mask) on susceptibility to infection and on infectiousness, producing detailed epidemiological insights that can inform efficient and effective public health interventions. This project will extend these models in three ways: (1) developing efficient Bayesian methods to incorporate pathogen genetic sequences into parameter estimation to reduce bias and variance; (2) developing, evaluating, and refining methods to evaluate model fit and estimate secondary attack risks and infectiousness profiles; and (3) developing graphical and statistical methods for the identification and control of confounding and selection bias in studies of infectious disease transmission.